Investigating mechanisms of bystander CD8 T cell mediated immunopathology

Project Abstract
Defining mechanisms of CD8+ T cell immune dysfunction is critical to treating immune-mediated diseases.
Bystander memory CD8+ T cells, in particular, are known to be protective to the host by supporting pathogen
clearance and infection control early in an infection by producing and responding to pro-inflammatory cytokines
and direct killing of infected cells. However, in some human disease contexts, dysregulation of bystander
memory CD8+ T cells has led to immunopathology and poor disease outcomes. The factors that drive this
phenomenon are unclear. We developed a mouse model to explore the pathological contexts and
consequences of bystander memory CD8+ T cells. In our model, immunity to lymphocytic choriomeningitis
virus (LCMV) leads to impaired control of an infection with the unrelated bacteria, Listeria monocytogenes
(Lm). Our preliminary data indicate that mice carrying increased frequencies of LCMV-specific memory CD8+ T
cells (P14 TCR transgenic cells) die following wild type (WT) Lm. Additionally, our preliminary data suggest
that exaggerated inflammation is not the cause of this pathology, as LCMV-immune mice did not have
improved bacterial clearance compared to naïve controls and they had markedly elevated levels of serum IL-
10, an anti-inflammatory cytokine. We hypothesize that elevated IL-10 and LCMV-specific bystander
memory CD8+ T cell sensitivity to IL-10 is central to dysregulated Lm control in our model. Following
this, abundant bystander memory CD8+ T cells cause fatal tissue damage by inappropriate cytolysis of
uninfected cells, via innate-like mechanisms. I propose the following aims to test these hypotheses: Aim 1
will identify the function of IL-10 during a bystander Lm infection of LCMV-immune mice, by IL-10RA blockade
and by ablating IL-10R on bystander memory CD8+ T cells. Aim 2 will determine the basis for bystander
memory CD8+ T cell induced lethal immunopathology by modulating P14 TCR CD8+ T cells to ablate genes
encoding key proteins involved in bystander immune responses. Together this proposal addresses an
important knowledge gap into mechanisms of immune dysfunction induced by bystander memory CD8+ T cells.

Public health relevance
PROJECT NARRATIVE CD8+ T cell dysfunction is poorly understood yet it underlies many immune-mediated, inflammatory diseases. In this proposal, I aim to investigate the role of bystander memory CD8+ T cells during systemic bacterial infection and how they may contribute to immunopathology. Outcomes of this proposed project will advance our understanding of protective and pathogenic and aberrant capacities of memory CD8+ T cells early in an infection and elucidate potential targets to ameliorate immune-mediated disease.